Predicting Attenuated Psychotic Symptoms Amongst Youth Endorsing Persistent Distressing Psychotic-like Experiences

Project Summary
Psychosis disorders are amongst the most debilitating and difficulty to treat forms of
psychopathology, necessitating the development of early identification and prevention efforts. The
development of early screening and prevention efforts requires first identifying reliable early risk
indicators of worsening psychosis spectrum symptoms. The development of psychosis is
preceded by the presence psychotic “like” experiences (PLEs) and then attenuated psychotic
symptoms (APS). Ideally, prevention efforts would identify youth prior to the functional decline
associated with clinical high-risk states (e.g., APS). Theoretical models posit that in order for PLEs
to worsen and develop into psychotic disorders, additional environmental exposures are required
(termed the persistence-proneness-impairment model). However, this theoretical model has not
been directly tested and therefore it is not yet clear how PLEs evolve into APS or what risk factors
predict which youth with PLEs will develop APS. Early prevention efforts have developed risk
calculators for conversion to psychosis, but questions remained regarding whether these
developed calculators will translate to the development of APS. The current application will
address these pressing questions by capitalizing on a unique and time-limited opportunity
provided by the Adolescent Brain Cognitive Development (ABCD) study. Aim 1 will examine the
prevalence of APS among youth in the ABCD Study sample, expanding initial data collection
efforts to provide robust estimates of APS amongst youth endorsing PD-PLEs and compare these
rates to persistent internalizing or externalizing symptoms, as well as compare rates of APS to
other forms of diagnosable psychopathology. The application will also identify predictors of
transition from PLEs to APS (Aim 2), including whether, consistent with the persistence-
proneness-impairment model, worsening environmental exposures over time predict transition to
APS. The applicant will also examine whether psychosis risk calculators developed for conversion
to psychosis also predict APS amongst youth endorsing PD-PLEs (Aim 3). The PI and her team
have the unique necessary experience to conduct this research. Thus, consistent with NIMH
Strategic Objective 3: Strive for Prevention and Cures, the present proposal will fill several gaps
in the extant literature, improving our understanding of the nature of early worsening psychosis
spectrum symptoms, including rates of APS and reliable risk factors in comparison to other forms
of psychopathology, information that will provide the foundation for screening and prevention
efforts.

Public health relevance
PROJECT NARRATIVE The development of early screening and prevention efforts for psychosis requires first identifying reliable early risk indicators of worsening psychosis spectrum symptoms. Youth expressing persistent (over several years) and distressing psychotic-like experiences (PD-PLEs) show lesser sizer impairments in the same domains as individuals will psychotic disorders, however it is unclear which youth with PD-PLEs are at most risk of worsening symptoms, including attenuated psychotic symptoms (APS). Consistent with NIMH Strategic Objective 3: Strive for Prevention and Cures, the current application will capitalize on a unique and time-limited opportunity provided by the Adolescent Brain Cognitive Development study to obtain estimates prevalence of APS, identify predictors of transition from PD-PLEs to APS, and determine whether psychosis risk calculators developed for conversion to psychosis also predict transition to APS, providing a foundation for the development of early screening and identification efforts.